Administrative Core

Admin Core Summary/Abstract
To operate a cohesive, coordinated and effective Program Project, the clinical, research, technology,
database/statistics and reporting components of the program require central coordination. The Administrative
Core of the proposed third renewal of this Program Project (PPG4) provides the organizational structure and
integration of the Program Project Cores and research. Another administrative function critical for success is to
liaison with other research programs on which the Program Project relies for success. In the case of PPG4, all
subjects will be recruited to the Clinical Core from two sources: 1) the University of Pittsburgh Alzheimer’s
disease Research Center (ADRC) and 2) The Pitt+Me® Research Participant Registry. The PPG4
Administrative Core will interface with the Administrative Core of the ADRC, which is now in its 36th year and is
a large and smoothly functioning clinical and basic research entity. PPG4 greatly leverages the ADRC
operations and facilitiating this interaction is the fact two mPIs of PPG4, Dr. Cohen and Dr. Aizenstein both
serves as Core/ Component directions within the ADRC and Dr. Ikonomovic and Dr. Villemagne both serve as
co-Investigators within the ADRC. Further, co-Investigator, Dr. Lopez is the Co-director of the ADRC, along
with co-Investigator Dr. Kofler. Also very important is the fact that Dr. Snitz, co-Leader of the Clinical Core of
PPG4 (and of PPG3), serves as the supervising neuropsychologist in the ADRC. Furthermore, Leslie Dunn
serves as the overall Administrator for both the ADRC and this Program Project. This continuity will allow for
the subjects to experience a relatively seamless transition into the PPG4 research program. The Administrative
Core provides the organizational structure and leadership for planning and implementation of all activities
aimed at the fulfillment of the Program Project aims. The specific aims of the Administrative Core are: (1)
Supervision of all Program Project functions (scheduling meetings, setting and evaluating milestones, data
requests, resolving conflict and ensuring open communication among Program Project investigators and staff).
(2) Management of Program Project budget, including expenditures and allocation of funds according to
Program Project priorities and distribution of Core resources. (3) Monitor compliance with Federal and
University policies and procedures, such as NIH Public Access Policy, Data Sharing Plan, and Conflict of
Interest. (4) Monitor compliance with Human subjects research, including liaising with University of Pittsburgh
Human Research Protections Office, the University of Pittsburgh Education and Compliance Support for
Human Subject Research. (5) Manage all reporting to the University of Pittsburgh Human Research
Protections Office, the Food and Drug Administration ([18F]MK6240, [11C]PiB, and [18F]SMBT-1 INDs);
Cerveau ([18F]MK6240 MTA). (6) Administrative oversight of the Program Project Database. (7) Liaise with the
University of Pittsburgh ADRC in the Department of Neurology. (8) Organize External Advisory Meetings.